The Role of Brain-Specific Angiogenesis Inhibitor 2 (BAI2) in Synaptic Structural Organization and Functional Dynamics

PROJECT SUMMARY
Excitatory ionotropic synapses and their associated dendritic spines play critical roles in fundamental
information processing within the brain. The development and morphology of these synapses are highly
functionally relevant; previous studies have established that patients with many different neurodevelopmental,
neurodegenerative, and neuropsychiatric conditions are clinically defined by synaptopathies. Synaptopathies,
or disease at the level of the synapse, includes inappropriate loss of synapses and spines, enhanced or
lowered synapse and spine development, and aberrations to the synaptic structure that leads to dysfunctional
signaling. The Brain-specific angiogenesis inhibitor (BAI) subfamily of neuronal adhesion G-protein coupled
receptors (aGPCRs) are a three-member postsynaptic family of receptors predicted to form trans-synaptic
complexes to direct synaptogenesis and synapse structural development. BAI2 is the least studied of these
proteins, with no established role in neuronal or synaptic development. BAI2 also appears to be the most
functionally non-redundant member of the BAI family. Though whole exome data from human patients with
autism spectrum disorder, schizophrenia, and bipolar disorder suggests all BAI proteins are implicated in these
conditions, BAI2 does not bind the same presynaptic proteins as BAI1 and BAI3. Furthermore, a gain-of-
function mutation to BAI2 is the putative cause of a rare spastic paraparesis condition in humans, and loss-of-
function mutations are associated with hyperactive behavior in mice. Addressing the fundamental role and
molecular mechanism of BAI2 thus can help us understand both basic synapse development, and potentially
inform future studies into treatments of psychiatric and central nervous system-derived motor disorders. To this
end, my data on BAI2 suggests that the protein localizes to the PSD and promotes both pre- and postsynaptic
development. I propose to further define the role of BAI2 in synapse and spine development by delineating the
functional domains that regulate synapse development (Aim 1.1), quantifying nanostructural changes to
synaptic structures (Aim 1.2), and describing functional deficits (Aim 1.3) induced by loss of BAI2. In the future,
I plan to pursue a postdoctoral position investigating real-time changes to excitatory and inhibitory synaptic
nanodomains and signaling in baseline, plasticity, and disease conditions (Aim 2).

Public health relevance
PROJECT NARRATIVE Ionotropic synapses are the specialized cell junctions that allow for chemical signals to be transmitted throughout the central nervous system; aberrations to synapse formation and development are defining features of numerous neuropsychiatric and neurodevelopmental conditions. This proposal aims to uncover the specific molecular mechanism by which the synaptic adhesion G-protein coupled receptor (aGPCR) Brain- specific angiogenesis inhibitor 2 (BAI2) facilitates synaptogenesis and synapse maturation across postnatal and adult development. Identifying and characterizing this molecular mechanism furthers our knowledge of synaptic development and may inform future pharmaceutical developments of aGPCR-mediated drugs.